Decoding the Heterogeneity of Interneuron Vulnerability in Aging and Alzheimer's Disease: An Ultraplex CLEM Approach

ABSTRACT
Age-related cognitive decline and Alzheimer's disease are associated with hippocampal interneuron loss and
hyperexcitability, which reflects the selective vulnerability of inhibitory neurons. Our preliminary data shows a
ubiquitous reduction of inhibitory synapses onto hippocampal CA1 stratum radiatum dendrites in aged rats
compared to young adults, regardless of their cognitive status. Aged rats that showed spatial learning deficits
had enlarged excitatory synapses on these same dendrites, disrupting local E/I balance, which is important for
learning and memory. In aged animals that maintained learning capacity, the remaining inhibitory synapses were
larger, thus preserving local dendritic E/I balance. These data suggest that while some interneurons are
vulnerable in the aging process, others are resilient and provide a potential compensatory role for maintaining
local excitation and inhibition. The broad heterogeneity of interneurons reflects subtypes with various molecular
profiles, firing rates, and differential targeting to specific CA1 dendrites. We hypothesize that specific interneuron
subtypes are more susceptible to age-related changes, while others are resilient and contribute to compensatory
learning mechanisms by maintaining local E/I balance. Studies that previously identified vulnerable interneuron
subtypes in the aging brain typically used techniques to isolate one interneuron subtype at a time, limiting our
understanding of how diverse interneuron populations interact and contribute to circuit function in the aging brain.
Furthermore, the subcellular organelles and local resources crucial for ultrastructural plasticity, such as
mitochondria, endosomes, smooth endoplasmic reticulum, and polyribosomes, remain largely uncharacterized
in these interneuron subtypes during aging. Consequently, we lack a comprehensive understanding of how
interneuron interactions and age-related alterations in their ultrastructural resources contribute to cognitive
decline or resilience. This knowledge gap is exacerbated by limitations in traditional techniques for identifying
interneuron subtypes that often compromise tissue quality, hindering ultrastructural analysis via serial section
electron microscopy (3DEM). We propose using a novel ultraplex correlative light and electron microscopy
(CLEM) method that allows for simultaneous identification of multiple interneuron subtypes via RNA and protein
markers in tissue optimized for 3DEM. In Aim 1, we will use ultraplex CLEM to quantify interneuron subtypes
and their subcellular structures in hippocampal tissue from behaviorally characterized aged rats, capturing any
intrinsic ultrastructural changes that occur in these cell populations. In Aim 2, we will use our new machine
learning tools to segment and reconstruct local interneuron circuits and synapses in distinct CA1 layers to identify
alterations associated with age-related cognitive decline and resilience. This approach will provide valuable
insights into the role of specific interneuron subtypes in maintaining E/I balance and cognitive function during
aging, ultimately contributing to our understanding of selective neuronal vulnerability in Alzheimer's disease.

Public health relevance
PROJECT NARRATIVE Neurons involved in learning and memory respond differently as we age: some become susceptible to age related changes while others compensate to keep our brains working. This research aims to identify how the connections between these different types of cells respond to aging and what internal cell features support cell resilience. In doing so, we hope to learn how these differences contribute to cognitive decline or resilience in aging and Alzheimer's disease.